Stop pulmonary airleaks with a novel inhaled dry powder aerosol

Project Summary Abstract
Over 30,000 Americans suffer each year from pulmonary airleaks leading to collapsed
lungs with painful, invasive treatments, and costly hospitalizations. Current treatments are not
effective enough in controlling airleaks and medical providers are seeking new therapies. There
is strong evidence that a locally delivered therapeutic via inhalation would have a major impact
on reducing the burden of this disease by promoting closure of the airleak directly. However, there
are no approved therapies to achieve the aim of quickly resolving airleaks via inhalation, and
effective treatment remains a significant unmet need.
Therefore, we are developing a minimally invasive inhaled aerosol that aims to seal an
airleak quickly and efficiently in the lung to prevent painful procedures and costly hospitalizations.
The goal of this Phase I project is to develop and test the feasibility and efficacy of our novel
inhaled dry powder aerosol formulation using an in-vivo pulmonary airleak model. Successful
completion of this Phase I effort will position us to demonstrate safety in an in-vivo toxicology
study and prepare for a first-in-human clinical study. Translation of this technology into a clinically
beneficial medical product has the potential to significantly improve the lives of patients with
pulmonary airleaks.

Public health relevance
Project Narrative Over 30,000 Americans suffer each year from airleaks leading to collapsed lungs with painful, invasive treatments, and costly hospitalizations. There is strong evidence that a locally delivered therapeutic would make a major impact on reducing the burden of this disease. Therefore, we are developing a minimally invasive inhaled aerosol that aims to quickly and efficiently seal an airleak in the lung to prevent painful and costly complications.